National Alzheimer's Coordinating Center

PROJECT SUMMARY
NCRAD plays a key leadership role in study protocol development and site training. NCRAD
utilizes standardized approaches to sample banking, storage, and retrieval. Over the past
decade, DNA banking at NCRAD has become a standard practice for all ADRCs. NCRAD now
maintains DNA from 29,424 ADRC-evaluated research participants with a uniform dataset
(UDS) and another 3,823 with the previously developed minimal dataset. Full longitudinal
clinical data for these samples are housed at the NACC with a limited data set of key variables
transferred to NCRAD. NCRAD is now broadening the range of blood-based samples banked
from the well characterized ADRC participants. With the rapid development of blood-based
biomarkers, there is an urgency to have a central laboratory in the United States that can
process large numbers of samples in a standardized manner. NACC and NCRAD will
collaborate on collecting the blood sample data and providing incentive payments to the ADRCs
via modifying the existing subaward agreements at NACC as well as build more efficient data
systems to store large data to be easily accessible by the data group and admin team at NACC.

Public health relevance
PROJECT NARRATIVE NCRAD plays a key leadership role in study protocol development and site training. NCRAD utilizes standardized approaches to sample banking, storage, and retrieval. Over the past decade, DNA banking at NCRAD has become a standard practice for all ADRCs. NACC will collaborate with NCRAD on collecting the blood sample data and providing incentive payments to the ADRCs via subaward modifications at NACC as well as creating a more efficient data system.